Matrix Metalloproteinase Regulation of Leukocyte Infiltration during Wound Repair

DESCRIPTION (provided by applicant): Upon loss of existing tissue integrity, wound closure is critical for maintenance of the protective epidermal barrier that shields the host from environmental insult and prevents water loss. An essential, initial response during wound repair is the influx of circulating leukocytes that cleanse the wound and also provide activators and growth factors to stimulate fibrogenesis and neovascularization. Members of the matrix metalloproteinase (MMP) family, such as MMP3, are potential key regulators of leukocyte infiltration. MMP3 is upregulated in the epidermis during processes undergoing tissue remodeling. Mice which are null for MMP3 have delayed closure of excisional wounds and demonstrate reduced infiltration of leukocytes in a number of model systems. Furthermore, we find that MMP3-/- animals have an increased sensitivity to SCC progression that is associated with a reduction in neutrophil and macrophage infiltration evident throughout all stages of tumor progression. Based upon these observations, we propose that MMP3 regulates a protective host defense response during wound repair that is reflective of a protective, antitumorigenic response during SCC. A number of molecules known to affect immune cell function can be directly targeted for hydrolysis and release by MMP3 or matrix proteinases which are activated by MMP3. We hypothesize that MMP3, in combination with other matrix proteinases, directly enhances leukocyte extravasation that subsequently influences the wound repair process. Leukocyte infiltration into sites of inflammation requires the coordinate regulation of multiple steps including arrest on endothelium, migration through the endothelial barrier and directed migration through connective tissue towards the site of inflammation. MMP3 is expressed by a variety of cell types including keratinocytes, fibroblasts, endothelial cells and monocytes and can activate other matrix proteinase classes; thus, MMP3 and other MMPs may modulate multiple key steps required for optimal leukocyte extravasation. The goal of this project is to elucidate the functional role of MMP3 in leukocyte extravasation during wound healing. Our specific aims will test our hypothesis as follows: Specific Aim 1: To identity the cellular matrix proteinase contributions of leukocytes, fibroblasts and keratinocytes to MMP3 dependent leukocyte infiltration into the wound environment using in vivo mouse models that are null for or have targeted overexpression of individual MMP family members. Specific Aim 2. To test the hypothesis that MMP3 activity regulates activation of subsequent MMP family members in wounded epidermis. Specific Aim 3: To identity the cellular mechanisms regulated during MMP3 and matrix protease dependent transendothelial migration in vitro. These studies will provide novel insights into the role of MMP3 and other matrix proteinases during leukocyte transendothelial migration and provide an in vivo model system for testing MMP inhibitors in a clinical setting.

Public health relevance
PUBLIC HEALTH RELEVANCE: Wounding of the skin requires healing to maintain normal health. An essential part of wound healing is inflammation. Matrix Metalloproteinases such as MMP3 may play a key role in regulating inflammation during wound healing. Narrative/Lay Sentences: Wounding of the skin requires healing to maintain normal health. An essential part of wound healing is inflammation. Matrix Metalloproteinases such as MMP3 may play a key role in regulating inflammation during wound healing. __SpecificAimsTextDelimiter__ Matrix Metalloproteinase Regulation of Leukocyte Infiltration during Wound Repair A. Specific Aims Wound closure is critical upon loss of existing tissue integrity for maintenance of the protective epidermal barrier that shields the host from environmental insult and prevents water loss. An essential, initial response during wound repair is the influx of circulating leukocytes that cleanse the wound and also provide activators and growth factors to stimulate fibrogenesis and neovascularization. Orchestration of this leukocyte infiltration may potentially occur through members of the matrix metalloproteinase family, such as MMP3. MMP3 is upregulated in the epidermis during processes undergoing tissue remodeling such as during wound repair. Mice which are null for MMP3 have delayed closure of excisional wounds, and our preliminary studies indicate that reduced infiltrate of monocytes in MMP3 null animals is evident during wound repair as well. In squamous cell carcinoma (SCC), a type of "non-healing wound", we find that MMP3-/- animals have an increased sensitivity to SCC progression that is concomitant with a reduction in neutrophil and macrophage infiltration evident throughout all stages of tumor progression. We have generated transgenic mice with MMP3 targeted to the epidermis. Initial studies characterizing these mice with keratinocyte-targeted MMP3 overexpression indicate an enhancement of neutrophils during the early stages of wound repair as compared with litter matched wildtype controls. Based upon these observations, we propose that MMP3 regulates a protective host defense response during wound repair that is reflective of a protective, antitumorigenic response during SCC. A number of matrix and non-matrix MMP3 substrates identified include those known to affect immune cell function. We hypothesize that MMP3 directly enhances leukocyte extravasation during wound repair processes. Leukocyte infiltration into sites of inflammation requires the coordinate regulation of multiple steps including arrest on endothelium, migration through the endothelial barrier and directed migration through connective tissue towards the site of inflammation. MMP3 is expressed by a variety of cell types including keratinocytes, fibroblasts, endothelial cells and monocytes; thus, MMP3 may modulate multiple key steps required for optimal leukocyte extravasation. The goal of this project is to elucidate the functional role of MMP3 during leukocyte extravasation. These studies will provide novel insights into the role of MMP3 and other MMPs whose activity is modulated by MMP3 during leukocyte transendothelial migration and provide an in vivo model system for testing of MMP inhibitors in a clinical setting. Our specific aims will test our hypothesis as follows: Specific Aim 1: To test the hypothesis that the combination of leukocyte, fibroblast and keratinocyte MMP3 activities is required for optimal leukocyte infiltration into the wound environment. To determine which cellular populations contribute to the MMP3-dependent response on leukocyte infiltration and wound closure. We propose to use our in vivo murine models that have selective gene ablation or that selectively target MMP3 to keratinocytes to determine the influence of MMP3 localization on leukocyte infiltration during wound repair processes. Leukocyte populations in wounded epidermis will be liberated and analyzed by flow cytometric analysis, in addition to using standard immunohistochemical analysis of tissue sections from wounded epidermis to determine associated cellular functional alterations. Specific Aim 2 To test the hypothesis that MMP3 activity regulates activation of subsequent MMP family members in wounded epidermis. To determine, in vivo, the temporal and spatial patterns of MMP proteolytic activities during wound repair. MMP proteolytic activities will be analyzed in vivo using optical proteolytic nanobeacons designed to register general MMP activities and for MMP3 or MMP9 selective activities. Specific Aim 3: To test the hypothesis that MMP activity regulates leukocyte migration and MMP3 activity regulates leukocyte transendothelial migration by controlling leukocyte adherence to endothelial monolayers. A) To determine whether MMP3 or MMP activities regulate leukocyte migration. Leukocytes isolated from WT and MMP null animals will be assayed for ability to chemoattract, and the migration velocities and paths will be compared using traditional static as well as microfluidic chemotaxis chambers. B) To determine whether either MMP3 or proteases activated by MMP3 regulate leukocyte- endothelial adhesion and attachment to control leukocyte transendothelial migration. Leukocytes isolated from WT and MMP null animals will be assayed ± MMPI for transendothelail migration, attachment and adherence to microvascular endothelial cells lines or to immobilized Fc/Adhesion receptors using static culture systems or microfluidic parallel-capillary perfused bioreactors.